Neural Substrates of the long-duration response

PROJECT SUMMARY
A major limitation of dopaminergic therapy for Parkinson’s disease (PD) is motor response “wearing-off” within
a few hours after the dose. Although the field has focused on prolonging the short-duration (acute) response of
each dose using more persistent drug preparations and delivery methods, these pharmacological approaches
have limited and short-term benefits. Wearing-off is driven by a decline in the duration of benefit of each dose,
due to the decay of the long-duration response (LDR) that lowers the trough level performance. We recently
showed the importance of task-specific learning and the striatopallidal pathway in LDR induction and decay.
Interestingly, our preliminary data suggest that repeated optogenetic stimulations of globus pallidus externa
(GPe) parvalbumin (PV)-expressing neurons – part of the striatopallidal pathway – induced long-term rescue:
mice showed improved locomotion when reintroduced to the same open-field environment ≥24 h after the final
stimulation session. This resembled LDR induced by repeated L-DOPA treatments. However, while LDR
induced by L-DOPA was selective to the induction context, LDR induced by stimulation of GPe PV+ neurons
transferred to a new context. Thus, repeated stimulation of GPe PV+ neurons conferred long-term motoric
benefits but may also reduce discrimination learning. This project aims to uncover the mechanisms underlying
these properties of LDR. GPe PV+ neurons consist of two subpopulations: those that project to substantia nigra
vs. to parafasicular thalamus. We will establish how the activities of these two GPe subpopulations are altered
during parkinsonian locomotion impairment and during different phases of LDR, both for LDR induced by
L-DOPA and by GPe PV+ neuronal stimulation. We will also examine whether perturbing these two GPe
subpopulations results in dissociable effects on long-lasting locomotion rescue vs. its context selectivity. This
project will advance our knowledge in the role of the striatopallidal pathway in mediating LDR, and elucidate
both therapeutic utility and potential side effects of GPe deep brain stimulation.

Public health relevance
PROJECT NARRATIVE The effectiveness of the widely prescribed drug, levodopa, in treating motor impairment in Parkinson’s disease declines over time, in part due to a progressive shortening in the time for which each dose of levodopa is effective. We recently found that repeated optogenetic stimulation of a specific neuron type in the external globus pallidus – the parvalbumin-expressing neurons – led to long-term rescue of locomotion deficit in parkinsonian mice, which recapitulates aspects of levodopa’s long-term rescue (its “long-duration response”). This project will examine the neural circuitry that underlies this beneficial effect of external globus pallidus stimulation; its elucidation will advance our knowledge of both therapeutic utility and potential side effects of globus pallidus deep brain stimulation for Parkinson’s disease.